Support for University Biomedical Excellence at UPR-RP

Project Summary/Abstract
The Río Piedras RISE Program is requesting funding to continue to provide its twenty-five (25) undergraduates
and thirty (30) doctoral research assistants with excellent opportunities to carry out research and to participate
in program activities aimed at their professional development. Since RISE is a research-intensive program, all
students will be expected to present their research results at national meetings and doctoral students will be
expected to publish their results in international journals. Undergraduates will also participate in summer
research internships at external sites and funds will be provided to those doctoral students who desire to carry
out special experiments at other universities. The RISE Program will continue to provide seminars, technical
workshops and special courses directed towards strengthening and enhancing the research capabilities of all its
students. In this respect, it will seek to assure that, as in the past, the large majority (> 90%) of the undergraduate
students successfully pursue doctoral studies in outstanding research universities. At the graduate level the
program will not only seek to assure that, as in the past, the large majority (>70%) of doctoral students continue
post-doctoral research experiences in prestigious laboratories, but that they complete their Ph.D. degrees in a
timely manner.

Public health relevance
PROJECT NARRATIVE The Rio Piedras Campus is requesting funds for the competitive renewal of its RISE program and this includes 25 undergraduates and 30 doctoral students. The program will continue to develop and improve activities in a manner that will allow it to assure that 90% of the undergraduates enter research doctorates and 70% of the doctoral students continue postdoctoral experiences. It will also assure that these students receive the necessary preparation to compete as effective researchers.